IGF::OT::IGF OPERATION OF GOVERNMENT-OWNED CONTRACTOR-OPERATED (GOCO) R&D FACILITIES

CPTAC will develop a community resource of multiple reaction monitoring (MRM) and/or Immuno-MRM assays that will detect and quantitate human proteins for lung cancer panels to complement targeted genomic panels currently used in the clinic, and other panels as needed.